A workplace multilevel intervention to reduce sugary beverage intake: Can the Compulsive Eating Phenotype guide better treatment matching, and does it work through predicted mechanisms of action?

A workplace multilevel intervention to reduce sugary beverage intake: Can the Compulsive Eating Phenotype
guide better treatment matching, and does it work through predicted mechanisms of action?
SUPPLEMENT ABSTRACT
Sugar-sweetened beverages (SSBs) have emerged as a key dietary risk factor for obesity and type 2 diabetes. We
have a new NIDDK-funded trial of the Metabolic Health Improvement Program (MHIP), a randomized controlled trial of
a multilevel workplace intervention on a diverse sample, that combines an employer-sponsored sales ban on sugar
sweetened beverages (SSBs) with brief counseling (recruitment beginning February 2023).
This one-year supplement provides a time sensitive opportunity to build the scientific infrastructure to implement and
conduct a thorough “science of behavior change” analysis of why an already successful multilevel intervention works,
targeting three candidate mechanisms of change (cravings, stress, efficacy). We are focusing on the high-risk subgroup of
those with compulsive eating, with implications for treatment matching, and exploring ethnic/racial and occupational
group differences as well.
We extend aims of the parent study to discover the MHIP multilevel intervention’s mechanisms of action. Based on
our pilot data and focus groups, we propose that being high on the compulsive eating phenotype (CE) increases
vulnerability to daily triggers of SSB intake – craving, psychological stress, low self-efficacy and that the brief counseling
works in part through these mechanisms. This supplement will allow us to build the infrastructure to assess the CE
phenotype, measure the process of change by adding frequent SMS text-based assessments of our proposed daily
behavioral mediators (SSB craving, psychological stress, and self-efficacy) and outcome (SSB intake) at 6 timepoints
(baseline, immediately post intervention, one month later after last booster session, and then during maintenance (3, 6, and
12 months later).
We will characterize a high CE phenotype by assessing links with metabolic disease and high sugar intake (Aim 1),
determine whether individuals with high CE synergistically benefit from a workplace multi-level intervention with sales
ban and counseling (Aim 2), and ascertain whether any increased benefits are due to reduced daily behavioral mediators
of SSB intake (craving, psychological stress, and self-efficacy) (Aim 3). Clarifying the mechanisms of action has
importance for the broader science of behavior change and the creation of more effective interventions for obesity and
metabolic disease.

Public health relevance
PROJECT NARRATIVE The parent study rigorously tests the impact of a multilevel intervention (hospital sales ban on sugary beverages and brief counseling) on obesity. The supplement will add the assessment of the compulsive eating phenotype as a moderator to assess whether people with this phenotype benefit most from the combination condition, showing the greatest reductions in sugary beverages and improvements in metabolic health. Lastly, we will test the mechanisms of action – whether the compulsive phenotype works through influencing cravings, stress, and self-efficacy, and whether the combined intervention targets these mediators.